Thrombotic Susceptibility in Veterans: Influence of prediabetes

Background, Innovation, and Impact to Veterans Healthcare: Thrombotic complications like myocardial
infarction (MI), stroke and venous thrombosis are the leading causes of morbidity/mortality in elderly, and are
common triggers for hospitalization in Veteran Health Administration system. Further, the risk factors
encountered during young or middle age may predispose to early thrombotic outcomes. For example, the
incidence of pre-diabetes in US is increasing, including in Veterans, and a growing literature in last 5-8 years
has linked prediabetes to arterial and venous thrombotic outcomes in aged as well as young cohort. In
Veterans, thrombotic complications are apparent prior to a clinical diagnosis of diabetes is established,
suggesting a link to prediabetic state. Therefore, a major goal of this proposal is to understand the early
mechanisms of increased susceptibility to arterial and venous thrombosis in understudied prediabetic young
and middle-aged Veterans. Findings from our on-going studies in Veterans establishes that while a moderate
platelet activation occurs in healthy middle-aged, a greater effect is seen due to prediabetes regardless of age.
Moreover, the increased platelet activity is inhibitable by decreasing mitochondrial reactive oxygen species
(mito-ROS) with SOD-mimetic. However, the molecular mechanisms for increased mito-ROS generation
remain to be determined. Our novel pilot data suggests that a defect in electron transport chain (ETC) and
altered metabolic pathways such as fatty acid oxidation upstream to ETC may lead to premature electron
leakage and could be the key mechanisms of ROS-burden within mitochondria. We will test the innovative
hypothesis, that dysregulation in ETC is central to platelet activation and NETosis mediated arterial or venous
thrombosis in prediabetes and is partly modulated by age. The proposed study is conceptually novel because it
will first time define a unique role of ETC in thrombosis and has several innovative technical aspects, including
study of metabolic pathways in causing ETC dysregulation and study role of a common human polymorphism V16A
in SOD2 using a novel humanized SOD2 mouse model. Using blood samples from Veterans, mouse models of
aging and early diabetes, as well as hSOD2V16A and platelet-specific SOD2-KO models we will test the
hypothesis under two independent aims. Aim 1: Determine the mechanistic role of ETC and ETC-linked
pathways in regulating mito-ROS, platelet activation and arterial thrombosis in young and middle-age
prediabetic Veterans, and test contribution of endogenous SOD2. Aim 2: Determine whether ETC and ETC-
linked pathways within neutrophils regulate release of NETs, cfDNA/mtDNA/EVs and mediate venous
thrombosis in aged or prediabetic Veterans and test a role of endogenous SOD2. Significance and Path to
translation/implementation: This study is anticipated to make a significant positive clinical impact by
providing key insight into the mechanisms of age- and prediabetes-associated arterial and venous thrombosis
in the Veterans. Secondly, it will first time uncover the contributing role of a common SOD2 polymorphism in
the thrombotic phenotype, that may implement inclusion of V16A polymorphism in testing panel for
thrombophilia. Finally, the success of this proposal may support testing of MitoQ/GC4419 in the clinical trial for
antithrombotic effects in age/prediabetes.

Public health relevance
Veterans are at increased risk for heart attack and stroke as they age. These conditions occur due to blood clots in the blood vessels and are a primary cause of hospitalization and death in the elderly Veterans. Risk factors such as intermediate-diabetes or prediabetes encountered during mid-life may increase the disease burden. Therefore, this proposal will study early mechanisms in middle-aged as well as young and mid-life pre-diabetic Veterans for enhanced blood clot formation. We will particularly study how mitochondria a powerhouse of cell, impacts blood cell functions to promote clotting.